UJMT FGHF Launching Future Leaders in Global Health (LAUNCH) Research Training Program Admin Supplement

PROJECT SUMMARY
In this supplemental application, we request funding for one U.S. postdoctoral fellow and two LMIC postdoctoral
fellows who have been selected for the 2023-2024 cohort of the UJMT LAUNCH Program. The funding is
requested from three institutes, centers, or offices (ICOs) at the National Institutes of Health: NIEHS, ODP, and
ORWH. Each ICO would provide support for one candidate. Funding includes stipend, health insurance, travel-
related expenses, research, and site support. For our LMIC fellows, it also includes funding for short-term training
attachments in the US to enrich their research and training experience. This ad hoc funding will allow UJMT
LAUNCH to expand its pool of funded trainees in the 2023-2024 training cohort, thereby increasing the scope
and impact of the overall program.

Public health relevance
PROJECT NARRATIVE The UJMT LAUNCH Program has supported pre- and postdoctoral global health research for over a decade. Supplemental funding from the National Institutes of Health has allowed our program to increase the number of supported trainees each year. This administrative supplement details the 2023-2024 training candidates with confirmed or pending ad hoc funding from participating institutes, centers, and offices within the National Institutes of Health.